Cellular and molecular mechanisms involving SLAMF1 during pulmonary fungal infection

PROJECT SUMMARY/ABSTRACT
Lung cellular resistance against microbes requires a signaling network involving stroma and innate myeloid
and lymphoid cells. To date, the signaling receptors and pathways are incompletely understood. Signaling
Lymphocyte Molecule Family (SLAMF) receptors are widely expressed among hematopoietic cells and lung
epithelial cells making them ideal candidates to orchestrate phagocyte killing of microbes. We recently reported
that during pulmonary infection with the fungus Blastomyces dermatitidis (Bd), SLAMF1 is required for innate
immunity and dispensable for priming vaccine-induced CD4+ Tcells. In preliminary data, we found that
SLAMF1 is required for killing of the yeast by neutrophils and monocytes in vivo, but the receptor is dispensible
for killing in vitro. These findings suggest that extrinsic, SLAMF1 dependent signals activate phagocytes to kill
yeast in vivo.
In this application, we propose to elucidate where and how SLAMF1 receptors endow phagocytes with the
ability to kill yeast in vivo during pulmonary fungal infection. We hypothesize that innate lymphocytes and
CCR2+ monocytes are required for SLAMF1-mediated neutrophil activation. We also posit that SLAMF1
mediates its function through homophilic (SLAMF1:SLAMF1) interactions between innate lymphocytes
and monocytes or through direct sensing of the yeast by SLAMF1. We provide strong preliminary data to
support our hypotheses. By using a panel of antibodies directed against 17 pulmonary leukocyte populations,
we found SLAMF1 staining on CD4+TCR+, TCR+, MAIT cells and Ly6Chi CCR2+ monocytes at 16 hours
post-infection. Our workplan in Aim 1 offers approaches that will elucidate the requirement of SLAMF1 on
lymphoid, myeloid or stromal cells for activation of neutrophil killing of yeast. In Aim 2, we will define the mode
of SLAMF1 action by distinguishing between SLAMF1 homophilic interactions among cells that express the
receptor vs. direct sensing of yeast by SLAMF1. Our work will identify new mechanisms of receptor-mediated
activation of innate effector cells and lay the groundwork for subsequent studies to advance detailed
mechanistic insight into how SLAMF1 orchestrates signaling and activation of neutrophils, as these cells are
the most potent effector to combat fungal and other microbial pathogens. This knowledge will provide the basis
for developing and designing new strategies for therapeutic treatments against fungi, and other pathogenic
microbes that require innate immunity for pathogen restraint.

Public health relevance
PROJECT NARRATIVE The number of fungal infections has risen dramatically in the United States over the last 15 years, and is now among the top 10 causes of death, partly because we lack novel and effective therapeutic drugs against fungi. To address this unmet medical need, we are working on understanding how the host senses and effectively restrains fungal growth. The knowledge gained will lead to the development of new and better strategies to therapeutically treat microbial pathogens.